Boston University Clinical and Translational Science Institute - U Program

DESCRIPTION (provided by applicant): The Boston University Clinical and Translational Science Institute (BU CTSI) is comprised of the BU Medical Campus (applicant), BU Charles River Campus, Boston Medical Center with its 15 Community Health Centers and Roger Williams Medical Center, in Providence, Rhode Island, along with partnerships with the Boston VAMC and Edith Norse Rogers Memorial Veterans Hospital. The Institute's vision centers on process improvement in providing resources and services, on game-changing disruptive innovations and on competency based team science education. Three highly interactive institute aims help create the most efficient system for clinical and translational research, develop creative scientific tools to expedite and retool traditional research processes, and train future translational scientists to do it. We will: 1) Create an Integrated Home for translational science that: A. integrates a pilot award program to target gaps in drug and device development; B. has a highly secure HIPAA compliant NIST-approved environment for data; C. contains efficiency measures for human subjects research; and D. incorporates new evaluation tools that assess processes and costs to be responsive to new opportunities and strategies. 2) Create an efficient delivery of Clinical and Translational Research Services to implement solutions that streamline and improve the quality, safety, efficiency and cost of clinical research. These include: A. skilld research personnel; B. an EMR-based Registry of ethnic populations; C. faster regulatory approval; D. consultative services for study design, biostatistics and bioinformatics; E. biobanking blood from our Registry for creation of iPS cells from normal subjects for drug toxicity screening; and F. creative tools to expedite and retool traditional research. 3) Create a Career Development Program for Future Scientists that: A. has a competency-based curriculum and evaluation approaches; B. supports a KL2 mentor based program in translational science; C. launches a new TL1 Program for supporting PhD scholars in translational science focused on regenerative medicine; D. provides mentor skill building tools to sustain high quality research mentoring; E. creates online self-directed modularized courses to enhance knowledge in informatics and other key translational research topics; F. implements an education evaluation plan and G. helps scientists with the downstream phase of commercialization of research. These associations and aims will support the mission of NCATS to change and speed the planning and implementation of clinical and translational research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Through an integrated home that builds upon institutional strengths, the mission of the BU CTSI is to catalyze the generation of innovative processes, methods and techniques that will enhance and speed the development, testing, and implementation of devices, diagnostics and therapeutics, across a wide range of human diseases and conditions. This will accelerate discoveries to improve the public health.